Mechanisms of transcriptional regulation by mutant p53

PROJECT SUMMARY
Mutation of the TP53 gene is frequent in human cancer with wild type (WT) p53 clearly being implicated as a
tumor suppressor. A growing body of evidence now supports the notion that tumor-associated mutant p53 not
only loses tumor suppressing activity, but also gains novel oncogenic roles. Although p53 has been shown to
have cytoplasmic functions, its role in controlling gene expression is certainly central to both its WT tumor
suppressing role and its mutant oncogenic function. The proposed research focuses on the transcriptional
responses of p53 spanning from normal tissue with exclusively WT p53, through effects of missense mutant
p53 in the presence of WT in the precancerous setting, to ultimately how mutant p53, in the absence of WT,
results in metastatic cancer. Three specific aims are proposed. In the first aim, we will determine how missense
mutation of one allele of p53 influences the remaining WT allele in the radiation response and tumorigenesis.
Previous cell-based studies have supported the notion that in such heterozygous genotypes, the mutant exerts
a dominant-negative effect on WT functions, relevant for tumor susceptibility disorders like Li-Fraumeni
syndrome, which is associated with germline single allele p53 missense mutation. Our preliminary data
examining the radiation response in vivo demonstrates that the m/+ genotype has an expanded transcriptome,
suggesting a complex interplay between the two p53 alleles. In the second aim, the effect of missense mutation
of p53 on basal gene expression and its contribution to tumorigenesis will be examined. We have shown that
WT p53 occupies genes and regulate their basal expression. These basal targets are regulated in a distinct
manner from those that are induced in stress responses that been well-studied in the past. Mutant p53 also
regulates basal gene expression and there is a subset of genes that overlap between WT basal targets and
those of mutant p53, which will be further explored. In the final aim, how mutant p53, in the absence of WT,
contributes to metastasis will be studied. A murine model for metastatic progression of esophageal squamous
cell carcinoma was developed by Project 3. Preliminary data shows altered gene occupancy and expression
during the transition from primary tumor to metastasis with upregulation of certain key targets: Csf1, Birc5, and
Slc7a11. The biological roles of the first two are a focus of Project 3, while the latter is being studied by Project
2. Findings will then be explored in the context of a mouse model for pancreas cancer developed by Project 1.
Given the essential role of transcriptional regulation in the activity of p53, it is postulated that downstream control
of specific target genes are key determinants of cellular outcomes. The existence of gained oncogenic activity
by tumor-associated mutant p53 thus provides the unexpected possibility for a targeted therapy involving a tumor
suppressor.

Public health relevance
PROJECT NARRATIVE The proposed research is focused on understanding the molecular basis of the tumor suppressor activity of wild-type p53 and the oncogenic functions of tumor-derived mutant p53. The long-term goal is to utilize this knowledge to improve diagnosis and design novel targeted therapies for a wide variety of human cancers.